Reducing blood pressure in mid-life adult binge drinkers: the role of microvascular function and sympathetic activity

Project Summary/Abstract
This supplement supports the diversity candidate, a second-year doctoral student in Kinesiology, and fosters
his research career development toward becoming a scientist in the field of vascular physiology and alcohol-
related health research. The research training and professional development activities, under this supplement,
are facilitated by a strategic mentoring plan and incorporated into the parent R00 project. The parent R00 grant
has been targeting microvascular function and sympathetic nerve activity to understand the mechanisms
underlying alcohol-attributable contribution to elevated systolic blood pressure and prevent the negative health
consequences in mid-life adults. Nevertheless, binge drinking, the most common pattern of excessive alcohol
use, can also cause elevated systolic blood pressure through increased arterial stiffness which, in theory,
results in hemodynamic changes, such as enhance aortic wave reflection and carotid artery wave intensity.
These hemodynamic changes play a significant role not only in blood pressure regulation but also in the
function of the heart and the brain. Understanding alcohol-induced arterial stiffening and the related
hemodynamic changes is significant because it helps predict the subsequent progression of organ injury by
alcohol. The diversity candidate will complete the proposed research to address the overarching hypothesis –
“chronic binge drinking contributes to the changes in aortic and carotid hemodynamic in mid-life adults due to
arterial stiffness.” During the supplement period, the diversity candidate will receive mentored training with the
PI of the parent project to enhance his knowledge and skills in alcohol use assessments and the harmful effect
of binge drinking on arterial stiffness and hemodynamics. He will also receive mentored professional
development to enhance his communication, leadership, and management skills, as well as professionalism.
The PI is a female early-stage investigator and is committed to career and professional development for her
trainees. The proposed training plan under this supplement will be facilitated by a senior faculty member, Dr.
R. Matthew Brothers. This supplement will not only help facilitate the candidate’s progress toward his next
stage of career, but also help enrich the PI’s reach program with the involvement of trainees from diverse
backgrounds and establish her laboratory at the early stage of her career. In addition, increasing the number of
scientists from non-traditional backgrounds (i.e., kinesiology) in the field of alcohol research will enhance the
diversity of alcohol research, ultimately accelerating the pace of research in alcohol-related health. Therefore,
this diversity supplement is consistent with the overarching mission and research priority areas of NIAAA.

Public health relevance
Project Narrative This supplement provides mentored training to foster the diverse candidate’s research career development and prepare him for the next stage of career – a postdoctoral fellow in the field of vascular physiology and alcohol- related health research. Through the proposed research, the candidate will advance the objectives of the parent R00 grant and further elucidate the mechanisms underlying alcohol-attributable contribution to elevated SBP, by targeting arterial stiffness and the related hemodynamic changes. By increasing the number of scientists from underrepresented minority population and non-traditional backgrounds, this supplement will enhance the diversity of alcohol research, ultimately accelerating the pace of research in alcohol-related health.